Task B07: Nonhuman Primate Model Development for Enterovirus D68 (EV-D68)

This contract provides for the development and standardization of non-human primate models of infectious diseases, and may include efficacy testing of candidate products, including GLP studies to support licensure.